Urban-Rural Disparities in Healthcare Quality for Children with Complex or Disabling Health Conditions

PROJECT SUMMARY/ABSTRACT
A total of 11.8 million children live in rural areas of the United States, and one-quarter of these children have
chronic health conditions. This population is more likely to have disabilities, less likely to receive preventative
care, and more likely to report unmet healthcare needs than children who live in urban areas. As such, they
represent an underserved group at high risk for disparities in health outcomes. Children with complex or
disabling health conditions may be at particular risk of adverse outcomes when they live in rural areas due to
their chronic and multifaceted healthcare needs. However, at a population level we know extremely little about
how urban-rural disparities in health care access impact this vulnerable population. The overall objective of this
proposal is to comprehensively evaluate urban-rural disparities in health care utilization and quality for children
with complex or disabling health conditions using five years of all-payer claims data from three states:
Colorado, Massachusetts and New Hampshire. These states represent diverse populations with respect to
geography, rurality, and race/ethnicity, making them ideally suited to the proposed analyses. We will conduct a
retrospective cohort study of approximately 140,000 children to: (i) identify urban-rural disparities in
ambulatory, emergency and inpatient healthcare utilization, (ii) characterize urban-rural disparities in
healthcare quality, (iii) identify community and health-system factors associated with urban-rural disparities in
healthcare quality, and (iv) construct patient-sharing networks among physicians who care for these children to
determine how patient-sharing networks differ between rural- and urban-residing children, and whether these
differences are associated with disparities in quality of care. Construction of physician patient-sharing networks
– that is, structural representations of relationships between physicians developed on the basis of shared
patients -– provides a systematic approach to identify relationships between physicians that exist outside of
formal organizational structures, which may be particularly relevant to children living in rural areas. In adult
populations, network characteristics have been associated with resource utilization, practice patterns, and
healthcare outcomes. However, this study will be the first to explore how physician networks differ between
urban- and rural-residing children, characterizing a modifiable health system factor that may be leveraged in
future work to reduce urban-rural disparities in their quality of care. This project will be conducted by a
multidisciplinary team with clinical expertise providing care for children with medical complexity, as well as
research expertise using all-payer claims data to evaluate healthcare quality and construct social networks.
This research will generate essential data to inform the subsequent implementation and evaluation of
interventions to reduce health disparities for rural-residing children with complex or disabling health conditions.

Public health relevance
PROJECT NARRATIVE One in five American children live in rural regions, and almost 3 million of these have chronic health conditions. The overall objective of this project is to analyze three States’ all-payer claims data to comprehensively evaluate urban-rural disparities in healthcare utilization and quality for children with complex or disabling health conditions, and to identify community and health system factors associated with these disparities. This research will be the first population-level analysis to characterize the magnitude of urban-rural disparities in healthcare quality for children with chronic and disabling conditions, generating foundational knowledge to improve clinical care and public health support for this vulnerable population.